Cognitive Enhancement for Persistent Negative Symptoms in Schizophrenia

7. PROJECT SUMMARY/ABSTRACT
Schizophrenia is one of the most disabling of all psychiatric conditions, and places significant burden
on the individuals who experience the disorder, as well as their family members and society. Advances in
pharmacotherapy and psychosocial interventions have led to significant reductions in hospitalization and
psychotic symptoms, and have provided opportunities for affected individuals to become more integrated
members of the community. Despite this significant progress, many individuals with schizophrenia remain
markedly disabled by persistent negative symptoms, including lack of motivation, social withdrawal, emotional
blunting, and poverty of speech. These negative symptoms are untreated by current pharmacotherapies and
are notoriously unresponsive to existing interventions, leaving patients and family members with little to no
options for treatment. Recently, there has been growing appreciation of the overlap between cognitive and
negative symptoms in schizophrenia, and psychosocial studies of cognitive remediation have begun to show
promise in treating negative symptoms by utilizing computer- and group-based exercises to enhance social
and non-social cognition. We have preliminarily observed in post-hoc analyses of three separate randomized-
controlled trials that Cognitive Enhancement Therapy (CET), an evidence-based cognitive remediation
approach for schizophrenia, can result in significant reductions in broad negative symptom domains. Further,
neurocognitive and social-cognitive improvement appear to underlie these symptom reductions, and point to
the enhancement of cognition as one of the most promising approaches for treating negative symptoms in
schizophrenia. To date, however, adequately designed trials of cognitive remediation interventions have yet to
be conducted in patients with moderate-to-severe and persistent negative symptoms to confirm these effects.
In response to RFA-MH-18-707, "Confirmatory Efficacy Clinical Trials of Non-Pharmacological Interventions
for Mental Disorders", this project proposes to conduct a confirmatory efficacy trial to examine the efficacy of
CET for the treatment of schizophrenia patients with significant and persistent negative symptoms. A total of
75 stabilized schizophrenia outpatients with moderate-to-severe persistent negative symptoms will be
randomized to 18 months of CET or an active, enriched supportive therapy control. Comprehensive data on
persistent negative symptoms, social and non-social cognition, and functional outcome will be collected prior
to treatment and at frequent 6-month intervals to (1) confirm the efficacy of CET for improving persistent
negative symptoms; (2) confirm the impact of cognitive target engagement on reduced negative symptoms;
and (3) examine the short-term durability of CET effects on negative symptoms and functioning. The results of
this project are expected to establish promising new avenues for the treatment of persistent negative
symptoms in the condition, and to significantly reduce the personal and public health burden associated with
schizophrenia.

Public health relevance
8. PROJECT NARRATIVE This project proposes to conduct a confirmatory study of the impact of cognitive remediation on moderate-to-severe persistent negative symptoms (e.g., lack of motivation and social withdrawal) in patients with schizophrenia. The information gathered through this project is of considerable public health significance in that it has the potential to establish a promising new avenue for treating ongoing negative symptoms in schizophrenia that do not respond to other treatments, to uncover the cognitive mechanisms that contribute to these symptoms, and to ultimately reduce the public health burden experienced by people living with this disabling psychiatric condition.